The Role of Family Contextual Factors in the Development of Emotion Regulation in Young Children on the Autism Spectrum

PROJECT SUMMARY/ABSTRACT
The majority of children on the autism spectrum have a co-occurring mental health disorder and emotion
dysregulation is posited to serve as a risk factor for the development of mental health disorders. However,
regulating emotions is a dynamic process that is influenced by the interplay of child characteristics and the
family context and there is a paucity of research examining these processes in children on the autism
spectrum. The long-term goal is to reduce the co-occurrence of mental health disorders in children on the
autism spectrum. The overall objective in this application is to clarify the associations between the family
context and children’s development of emotion regulation. The central hypothesis is that the strength and
direction of the associations between the family context and emotion regulation depend upon children’s
characteristics, including autism diagnostic status and the heterogeneity of autism symptom severity. The
rationale for the proposed research is that once we identify contextual factors associated with emotion
regulation, and for whom they are applicable to, then we can develop appropriate interventions to reduce the
development of co-occurring mental health disorders. The central hypothesis will be tested by pursuing two
specific aims: 1) Identify whether dynamics of emotion regulation differ for children on the autism spectrum
compared to non-ASD children and whether, among children on the autism spectrum, such dynamics vary as a
function of child characteristics; and 2) Identify the extent to which aspects of the family context, previously
identified in NT children, are associated with emotion regulation and whether child characteristics moderate
these associations. The PI’s preliminary studies indicate strong feasibility of recruiting a sample of young
children on the autism spectrum and measuring emotion regulation. The proposed research will include 220
children (110 ASD; 110 non-ASD) and their parents. The proposed research is innovative, in the applicant’s
opinion, because it represents a substantive departure from the status quo by using a multi-method design to
understanding the dynamics of emotion regulation in children on the autism spectrum and identifying which
children are most at risk for difficulties regulating emotions. The proposed research is significant because it is
expected to inform efforts to promote healthy emotional development in children on the autism spectrum.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because emotion dysregulation contributes to the development of most mental health disorders and the investigation of emotion regulation is a public health priority. Autism spectrum disorder impacts as many as 1 in 44 children in the USA -- the majority of which have a co-occurring mental health disorder—and this study will contribute critical knowledge that can be used to reduce mental health disorders in children on the autism spectrum. Thus, the proposed research is relevant to NIH’s stated priorities to understand emotional development among children on the autism spectrum.